Identification of Critical Thermal Environments for Aged Adults

PROJECT SUMMARY/ABSTRACT
This proposal directly addresses, in a uniquely innovative and direct approach, the stated goal of FAO PAR-19-
250: To better understand “exposure of the older person to changing environmental hazards in their daily
environment that raises their risks”. Men and women over the age of 65 are the most vulnerable population
during severe environmental heat events. While we know a lot about age-related declines in physiological
responses to environmental heat stress, there are key critical gaps in our understanding of the impact of
extreme weather on aging human populations as well as in ways to positively intervene. The present project
adds practical information: 1) by determining the integrated thermoregulatory response of men and women
over the age of 65 yrs to a wide variety of adverse environments and 2) by identifying the specific
environments that have significant adverse impact on older adults. The research approach will yield directly
translatable results that can be used for evidence-based alert communication, policy decisions, triage for
impending heat events, and implementation of other safety interventions. We will test the global hypothesis
that aging will shift critical environmental limits to a narrower range of safe environments across the
psychometric spectrum (encompassing warm-humid to hot-dry environments). The present proposal logically
builds on our 30-year body of mechanistic research on thermoregulation and aging and our experience in
executing this unique research paradigm. In Specific Aim 1 we propose to identify those environmental limits
above which age-related physiological changes cause uncompensable heat stress, resulting in heat storage
and increasing the risk of heat illness. As appropriate based on the data, distinct psychrometric limits will be
derived for older men and older women. We hypothesize that aging will decrease critical environmental heat
balance limits, particularly in warm-dry environments due to impairments in sweating mechanisms. In Specific
Aim 2 we will calculate critical evaporative coefficients and wet-bulb globe temperature isotherms that can be
used to predict environmental conditions that are uncompensable, and therefore increase health risks for older
men and women. These coefficients can subsequently be used to predict responses of older adults to a wider
set of environmental parameters (solar load, wind, etc.). Finally, we propose one additional exploratory Aim.
Our laboratory has identified additional detrimental effects of over-the-counter and commonly prescribed
platelet inhibitors on thermoregulation in older men and women. We have previously described how aspirin
(ASA) and prescription platelet inhibitors (clopidogrel; Plavix®) further accelerate the rise in body core
temperature in warm environmental conditions and impairs heat loss mechanisms. Therefore, we propose to
also determine the effects of ASA on age-specific critical environmental limits, hypothesizing that these drugs
will further decrease the critical environmental heat balance limits, particularly in hot humid conditions due to
impairments in dry heat loss mechanisms (Specific Aim 3).

Public health relevance
PROJECT NARRATIVE Men and women over the age of 65 are the most vulnerable population during severe environmental heat events, experiencing significantly worse health outcomes than any other age cohort. The global population of aged individuals is growing rapidly, resulting in an increasingly larger vulnerable population as the frequency and severity of heat waves continue to increase. While there is a vast literature detailing age-related declines in physiological responses to environmental heat stress, the significant question remains: In what specific environments does this age disparity begin to occur? Our laboratory originally developed, and has a long history of using, a unique, rigorous, and reproducible approach to identify critical environmental limits to prolonged heat exposure specific to older men and women. This research approach combines physiological and biophysical approaches to delineate safe from potentially unsafe environmental conditions for older adults from a human heat balance standpoint.